Core B-Modeling & Experimental Therapeutics Core

Core B (Modeling & Experimental Therapeutics Core) - Abstract/Summary
Genetically engineered mouse (GEM) models remain central to virtually all aspects of this P01 and have
contributed significantly to our understanding of both mouse and human pancreatic cancer. GEM models,
particularly those with inducible oncogenes, have enabled (i) elucidation of the role of specific genetic/pathway
alterations in tumor biological mechanisms such as autophagy and immunity, (i) dissection of cooperative
interactions between genetic elements such Kras* and different tumor suppressors such as p16ink4a, p53 and
Smad4, and (iii) deconvolution of the heterotypic interactions across different cell types of the tumor
microenvironment such as Kras* in cancer cells and TGFb in immune cells. In this renewal, two reasons
prompted us to establish this new Core. First, the extreme allelic complexity of the models employed in each
Project will benefit from dedicated sophisticated engineering. Along these lines, it is worth noting that our models
may harbor as many as ten genetic alterations. Core B’s ES-GEM system serves as a powerful platform to
introduce new alleles into existing multi-allelic ES lines harboring core PDAC-relevant alleles. Second, nearly all
aims propose preclinical experimental therapeutic trials with GEM models. Such trials will benefit from expert
execution with professional staff where standardized protocols would enable comparison of therapeutic regimens
across the P01. Here again, the ES-GEM system helps tremendously as it enables highly efficient generation
of large cohorts from one or two rounds of blastocyst injection to produce PDAC-prone mice that can be enlisted
into multi-arm trials. The ES-GEM system has been proven to generate experimental cohorts with all the
characteristics of a germline model. In addition, this approach dramatically reduces time and cost associated
with large breeding colonies for therapeutic experiments.

Public health relevance
Core B (Modeling & Experimental Therapeutics Core) - Project Narrative. Core B will generate new mouse models relevant to human pancreatic cancer. The Core will further provide the model systems and standardized protocols to perform trials that will test new drugs alone and in combinations. This Core is critical to the translation of our scientific discoveries into improved therapies for human pancreatic cancer.